Spectral Confocal Imaging Instrumentation for Forsyth Advanced Microscopy Core

Project Summary/Abstract
This is a proposal for the purchase of a laser scanning confocal microscope with fluorescence spectral
imaging, near-infrared imaging, and correlative microscopy capabilities. The instrument requested is
the Zeiss LSM 980 equipped with a 34-channel spectral detector, excitation diode lasers and beam
splitters, near infrared (NIR) laser and detectors, and a ZEN Connect software module to enable
correlative microscopy workflows. The instrument is critical to the research programs of the users and
will replace a decade-old instrument that no longer is guaranteed support by the manufacturer. It will be
placed in the Advanced Microscopy Core facility of the Forsyth Institute, an independent research
institute in Cambridge, MA, and will support the fundamental and applied research of 12 investigators—
including 5 Major Users and 7 Other Users studying the human oral microbiome, microbe-host
interaction, craniofacial bone structure, tooth enamel and salivary gland function. Specific projects for
which the instrument is needed by its Major Users include (1) mechanisms underlying spatial
interactions in the oral microbiota; (2) imaging studies of the structure and organization of oral bacterial
biofilms at micrometer and sub-micrometer scales; (3) immuno-fluorescence analysis of gene
expression and protein localization to understand the mechanisms of bone development, repair, and
regeneration; (4) the interaction of ultrasmall bacteria and their hosts on periodontitis and inflammatory
disease; and (5) characterization of the episymbiont TM7 with its host bacterial cell. In addition to the
enumerated projects, the purchase of this instrument will enable as-yet unfunded pilot projects to
explore promising research avenues for oral health and disease. Collectively, these research projects
support the overall mission of the Forsyth Institute to improve both oral and overall health through
targeted basic research as well as clinical service and outreach. Access to this instrument will enhance
the goals of these research projects by providing an accessible, reliable, and state-of-the-art instrument
to enable users to acquire images of the highest quality and biomedical impact using efficient
workflows. The technical expertise of the Core staff and a carefully constructed management plan will
permit maximal use of accessible user time on the instrument at the highest performance level. Strong
institutional support from the Forsyth Institute will guarantee operating support for the instrument and
will enable the purchase of an offline processing workstation for efficient high-throughput analysis of the
large imaging datasets that these projects will generate. In sum, the cutting-edge imaging
instrumentation requested in this application will advance the Institute’s research programs and NIH-
funded biomedical research.

Public health relevance
Project Narrative Innovative research is a central component of the Forsyth Institute's mission to improve oral and overall health. The purchase of a laser-scanning confocal microscope, the Zeiss LSM 980, is essential for the Institute’s research on key questions such as how bacteria in the human mouth affect one another and interact with their host’s immune system, how facial bones develop and can be repaired, and how proteins guide the arrangement and mineralization of tooth enamel.